Genes Assoc With Ovarian Develop /Premature Ovarian Fail

About 1-3% of all women undergo precocious menopause, either never going through menarche or stopping menstruation by the mid-30's, rather than reaching the standard reproductive lifespan of about 50. A fraction of such instances of early-onset "premature ovarian failure (POF)" is genetic. A single locus on chromosome 3 is implicated in several families. In collaboration with the group of Dr. G. Pilia, we isolated the gene, FOXL2, in which mutations cause POF and an eyelid malformation (constituting the syndrome Blepharophimosis/Ptosis/Epicanthus Inversus, or BPES). We are now analyzing the function of FOXL2, which appears to determine the level of ovarian follicles. We recovered the mouse orthologue, Foxl2, and generated a knockout mouse model. The resulting phenotype mimics eyelid and ovarian features seen in BPES. In the ovaries of the knockout mice, pervasive failure of follicle formation occurs. Complete individual follicles never form from primitive oocyte nests; development of all somatic lineages in the ovary is blocked; and all oocytes can subsequently be derepressed for growth and undergo apoptosis. The results point toward a comparable overall mechanism for POF in women deficient in FOXL2. To help understand the failure of follicle formation and maintenance in POF at a molecular level, we have analyzed normal ovarian development in mice using the NIA 15K cDNA microarray [developed by the group of Dr. M. Ko (LG)]. We have thus far compared the profile of genes expressed in ovaries of newborn mice, in which ovarian follicles are just starting to form, to the cohort of genes expressed in mature ovary, in which follicles are fully formed. Marker genes expressed in follicle cells only at birth, or in oocytes of nascent or in mature mice, have been recovered for further functional studies. These will be analyzed in comparison to the subset of genes whose function is sharply affected in hereditary POF, starting with the expression profiling of developing ovaries from Foxl2 knockout mice. In that model, the interruption of programmed and coordinated gene function will be characterized by determining the target genes regulated by Foxl2.